XtremeCT II high-resolution peripheral quantitative computed tomography (HR-pQCT) scanner

Project Abstract
In this Shared Instrument Grant application, we are requesting funds to acquire an XtremeCT II High
Resolution Peripheral Quantitative Computed Tomography (HR-pQCT) scanner. HR-pQCT is a non-invasive,
low radiation approach for assessing compartment-specific volumetric bone mineral density (vBMD) and bone
microarchitecture in the peripheral skeleton to estimate bone strength and fracture risk. Integration of this state-
of-the-art skeletal imaging modality into the repertoire of biomedical imaging tools available at Wake Forest
School of Medicine (WFSM) advances the initiatives of 18 NIH-funded centers, institutes, and departments; and
bolsters collaborative efforts with several of our regional partners. Specifically, acquisition of HR-pQCT
technology will allow the proposed major and minor user groups to: 1) better understand the effects of lifestyle-
based strategies — such as weight-bearing exercise and a high protein diet — on skeletal health among older
adults losing weight; 2) expand the investigation of the role of age-related biological changes in skeletal muscle
on the decline in mobility to include interactions with bone; 3) demonstrate the potential of advanced image
analyses techniques to augment histostructural outcomes; 4) provide insight into the genomic architecture of
bone health to aid in the development of novel treatment strategies to mitigate bone loss in aging; 5) better
capture musculoskeletal comorbidities among motor vehicle crash occupants, and understand their influence on
injury incidence and rehabilitation success; 6) address important gaps on the effects of weight management
interventions on the growing skeleton; 7) evaluate whether bone microarchitecture varies across ethnically
diverse populations; 8) augment computational modeling strategies assessing change in bone health across the
lifespan to include bone microarchitecture and strength; and 9) determine the timing of and extent to which
intracortical bone loss occurs among adults with diabetes mellitus and chronic kidney disease. To promote cost
effectiveness, encourage optimal sharing, and foster multidisciplinary collaborations, the HR-pQCT will be
housed in the Translational Imaging Program Core at WFSM, where it will be overseen by qualified leadership,
operational, and advisory committees in accordance with well-organized and self-sustaining administrative and
financial plans. Ultimately, the addition of a HR-pQCT system will enable WFSM to engage in more
multidisciplinary collaborations, compete more successfully for external research funding, and remain at the
forefront of musculoskeletal research endeavors.

Public health relevance
Project Narrative There is a successful and enthusiastic group of investigators at Wake Forest School of Medicine (WFSM) — including experts in biochemistry, biomedical engineering, comparative medicine/pathology, epidemiology and prevention, gerontology and geriatric medicine, hematology and oncology, and pediatrics — who have substantial need for a high-resolution peripheral computed tomography (HR-pQCT) scanner. Acquisition of HR- pQCT at WFSM will enable this group of investigators to expand their significant contributions to, and remain at the forefront of, research in the field of musculoskeletal health.